Prenatal per- and polyfluoroalkyl substances (PFAS) exposure and associations with common childhood infections and allergies: A study of risks and resiliencies in the ECHO Program

Per-and polyfluoroalkyl substances (PFAS) are detected in virtually all people in the U.S. and the
evidence of health effects at increasingly low levels of PFAS, is growing. Despite being used in
manufacturing since the 1940s, there was little awareness or research on the health effects of
PFAS until the last 15 years. A 2016 National Toxicology Program (NTP) systematic review
concluded that PFOA and PFOS are a presumed immune hazard to humans. In particular,
decreased antibody response has been identified as a critical endpoint for international, national,
and state toxicity values and drinking water regulations. Despite the regulatory importance,
research on the health consequences resulting from reduced immune function is not definitive.
Common childhood infections and immune hypersensitivity outcomes such as allergies are useful
measures for evaluating altered immune function in humans, and notably, no U.S. based cohort
study has evaluated these outcomes. Combing pediatric birth cohorts with available prenatal
PFAS serum concentrations from across the Environmental Influences on Child Health Outcomes
cohort, we will evaluate associations with childhood infections (bronchiolitis, croup, pneumonia
and bronchitis, ear infections) and allergies (allergy symptoms, and atopic dermatitis) at infancy
and early childhood. PFAS will be evaluated individually in adjusted linear and logistic regression
models and as mixtures using Bayesian Kernal Regression Models (BKMR). Potential effect
modification by breastfeeding, child sex, child BMI, and other factors will be evaluated to
understand differential impacts due to cumulative exposures. Dietary and demographic
determinants of PFAS will be assessed with correlation analysis and multivariable linear
regression across the ECHO-wide study and for each cohort to provide targets for further
reduction of PFAS exposure in U.S. pregnant women. Positive and null findings, alike, from well
conducted studies, will be important for understanding safe levels of exposure and guiding future
regulations.

Public health relevance
NARRATIVE No U.S. cohort to date has evaluated associations with per- and polyfluoroalkyl substances (PFAS) with measures of health consequence of reduced immune function including common childhood infections and some allergies, despite the use of decreased antibody response following vaccine as a critical endpoint for the regulation of PFAS. We propose to combine pediatric birth cohorts with available prenatal PFAS serum concentrations from across the Environmental Influences on Child Health Outcomes cohort, to evaluate associations with childhood infections (bronchiolitis, croup, pneumonia and bronchitis, ear infections) and allergies (allergy symptoms, and atopic dermatitis) at infancy and early childhood for individual PFAS and mixtures. Additional analyses will include effect modification by biological and sociodemographic factors to evaluate the cumulative impact of environmental stressors, as well as study of dietary and sociodemographic determinants of low-level PFAS exposure to develop guidance for reducing exposure among pregnant women in the U.S.